MECHANISM OF DRUG TRANSPORT IN LUNG CANCER CELLS

DESCRIPTION: Studies in the applicant's laboratory have demonstrated the presence of a novel mechanism capable of transporting both anionic glutathione-electrophile thioester conjugates (GS-E) as well as the weakly cationic chemotherapeutic agent, doxorubicin in erythrocyte membranes. The applicant hypothesizes that the mechanisms capable of shared transport of DOX and GS-E should be useful in modulating resistance to DOX as well as to other natural product chemotherapeutic agents. Preliminary studies of the kinetic properties of a purified and reconstituted 38KD erythrocyte membrane proteins support the hypothesis that this protein is capable of DOX and GS-E transport. A preliminary sequence analysis suggests that it belongs to the ABC family of transport proteins but does not match any of 33 ABC family transporter genes including MRP and related proteins. Studies in a H-69 human small cell lung cancer cell line and derived DOX resistant sublines indicate heterogeneity in GS-E inhibitable DOX transport mechanisms. The 38KD proteins was not detected, but two immunologically related proteins of molecular weights 64 and 109kD were found in H69 cells. A hypothesis is presented that DNP-SG ATPase represents a novel GS-E inhibitable DOX transport mechanisms with related proteins expressed in mammalian cells and that expression of this protein can determine susceptibility to chemotherapeutic agents. Studies are proposed in this application to: 1) isolate and characterize membrane transporters immunologically related to DNP-SGATPase in membrane fraction from several human cancer cell lines; proteins will be isolated using a novel DNP-SG affinity procedure and activity determined using a substrate stimulated ATPase assay. Kinetic properties, temperature and pH dependence and effects of substrates and inhibitors on the protein will be determined followed by peptide fragment analysis and amino acid sequencing. 2) determine the ability of each protein to mediate ATP-dependent active transport of GS-E and chemotherapeutic drugs against a concentration gradient in crude membrane vesicles and in artificial vesicles reconstituted with purified protein ; 3) determine the effects of differential levels of expression of DNP-SG ATPase and related transporters in different cells on drug sensitivity and on cellular drug transport using a cell flow system developed by the applicant and 4) study the interrelationship between transporters through molecular cloning of their cDNA using degenerate oligonucleotides based on the peptide sequence.